EFFECT OF CHARGE ON RETENTION OF COPPER RADIOPHARMACEUTICALS IN CLEARANCE ORGANS

Differential uptake of radiocopper labeled monocional antibody fragments and octreotide in the clearance organs has been correlated with the charge of the conjugated chelate (Anderson, et al.,J Nuci Med 1955; 36:850-858; Rogers, et al., J Lab Cmpd Radiopharm 1955; 37: 544-546). Hepatic and renal uptake has also been found for positively charged Cu-64 labeled azamacrocyclic ligands. We have compared the biodistributions of five Cu-64 complexes, TETA (-2 charge), 1,4.8,11-tetraazacyclotetradecane (cyclam), 1,4-ethano-1,4,8,11-tetraazacyclotetradecane (et-cyclam) (Jones-Wilson, et a., J Lab Cmpd Radiopharm 1955; 37: 462-464), 1,4,7.10-tetraazacyclododecane (cyclec) (each +2) and 1,4,7,10-tetraazacyclododecane-1,7-diacetic acid (DO2A) (neutral). Each complex was labeled in 100 % radiochemical purity as established by radio-TLC. Complex charge was established via electrophoresis at pH 7.34 and 5.45. Biodistribution, urine and blood metabolite studies were performed in female Sprague-Dawley rats. Renal clearance of Cu-64-TETA (-2) was rapid with greater than 80% of the activity in the bladder at 15 min post inj. However, each of the +2 complexes were retained in the kidney and liver to 24 hours post infection [%id/g: kidney cyclam (3.97+0.97), et-cyclam (4.19_0.42), cyclen (1.62+0.55); liver, cyclam (1.82+0.19), et-cyclam (1.65+0.36), cyclen (0.65+0.02)]. Analysis of urine samples indicated that each charged complex was excreted intact at all time points. Liver and kidney uptake was found for Cu-64-DO2A [15 min post in]: kidney (4.71+0.41), liver (1.51+0.16)], for the neutral complex. Renal activity decreased while hepatic activity remained constant over 24 hours [kidney (2.5+0.31), liver (1.38+0.14). Analysis of urine samples showed partial metabolism of the complex to several less polar species. The data indicate that the overall charge of the metal-ligand complex affects the clearance characteristics; therefore, chelate charge should be considered in the design of all metal based radiopharmaceuticals.